AMI FORUMS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The AMI Forum provides a forum for presentation of both the technical aspects of Core Research and Development Projects as well as the underlying biological motivation for the Collaboration and Service projects. The format is a 20-30 minute talk, accessible to a general audience, which provides an overview of the week's topic, followed by an informal discussion and questions. Typical attendance at a forum is between 30 and 60 people.